Measuring Word Understanding and Visual Attention Skills in Minimally Verbal/Non-Speaking Children with Autism

There are very few receptive language assessments which are appropriate for autistic children who are
minimally verbal/non-speaking.2,7 Because practitioners use outcomes from these assessments to create
intervention plans, identify appropriate augmentative and alternative communication (AAC) systems, and
inform vocabulary selection for AAC systems, receptive language measures are a vital component of
assessment and intervention for autistic children. Eye-tracking methods show promise as an alternative
assessment method for this population because they do not require verbal skills, social interaction, or an overt
motor response.10,11 The purpose of the proposed study is to examine the feasibility of using eye-tracking
technology as a measure of implicit word comprehension for autistic children who are minimally verbal/non-
speaking. The specific aims include (1) evaluating the feasibility of using eye-tracking technology, with pictures
and object-stimuli, as an implicit measure of word understanding in autistic children who are minimally
verbal/non-speaking, and (2) examining eye-movement variables which can be indices of word-understanding
in this population. This study will include 35 autistic children who are minimally verbal/non-speaking.
Participants will complete two experimental word-understanding eye-tracking assessments: a) an assessment
that uses objects as stimuli, and b) an assessment that uses picture stimuli. Aim 1 will evaluate percent
unusable data and percent completion of the two experimental eye-tracking tasks to add to the limited
available information regarding feasibility of eye-tracking with this population. Behavioral coding will be used to
describe participant behavior during unusable trials (i.e., trials with data loss) and during calibration failure.
Unusable data may be a result of attentional difficulties, excess movement, or noncompliance. Results from
behavioral coding will provide nuanced information about participant behavior during unusable trials which has
not been reported in prior studies. This information is important for understanding how to mitigate the
occurrence of unusable trials in future studies. Aim 2 will collect preliminary data on eye-movement variables
which may be indices of word-understanding in minimally verbal autistic children. Due to the heterogeneity of
this population and the systematic exclusion of children with minimal verbal skills from previous research on
eye-tracking in autism, there is very little empirical evidence on eye-movement variables which may indicate
word understanding for autistic children with minimal verbal skills. This research will address a need identified
by NIH to develop and evaluate assessments of receptive understanding for autistic children who are minimally
verbal/non-speaking (NOT-DC-23-009).

Public health relevance
The lack of valid and reliable receptive language measures for autistic children who are minimally verbal/non- speaking is a significant barrier to inclusion of this subgroup in autism research and has led to a dearth of evidence-based clinical practices for this population. The proposed study aims to examine the feasibility of using eye-tracking technology as a measure of implicit word comprehension for autistic children who are minimally verbal/non-speaking. The proposed study directly addresses the NIDCD’s recent Notice of Special Interest to promote language and communication in minimally verbal/non-speaking individuals with autism by utilizing novel technologies to develop and evaluate assessments of receptive understanding for autistic children who are minimally verbal/non-speaking.